VISUAL FUNCTION AND OCULAR PIGMENTATION IN ALBINISM

Patients with hypomelanotic disorders such as ocular albinism, oculocutaneous albinism, Chediak-Higashi disease, Hermansky-Pudlak syndrome, and iris trans-illumination defects are being recruited to determine visual function in these conditions and to evaluate its course over time. Family members are evaluated to attempt to determine factors which may identify the heterozygous state.